ESTROGEN FEEDBACK SIGNAL ON THE GONADOTROPIC, SOMATOTROPIC AND LACTOTROPIC AXES

The nature and magnitude of the feedback actions of estradiol on the gonadotropic axis (negative feedback) and the somato and lactotropic axes (positive feedback) are specified by the time-course of steroid delivery; i.e. pulsatile versus the time-invariant estradiol secretion/infusion. These data are being analyzed now. CORE LAB ONLY.